Synthetic biology approaches for bio-orthogonal labeling of circular RNAs

SUMMARY
The key challenges for RNA therapeutics are delivery and stability inside of cells. Circular RNAs that lack a
5’ and 3’ end are resistant to intracellular degradation, which allows them to persist for much longer than
linear RNAs. Meanwhile lipid nanoparticle encapsulation of RNA has improved stability in serum and
delivery of RNAs to cells. However, all RNA-based therapies are currently limited by inefficient escape from
endosomes. Even when encapsulated in LNPs, less than 1% of RNAs are able to efficiently escape from
endosomes. Yet, evidence exists that endosomal escape of siRNAs can be improved by conjugating RNA
with hydrophobic lipids. These groups are thought to destabilize the endosome membrane, facilitating
escape to the cytoplasm, where they can exert their therapeutic effect. While it is possible to add
hydrophobic lipids to chemically synthesized small RNAs, this is more difficult for mRNAs and circular RNAs
that are typically produced by in vitro transcription. Chimerna scientists have developed a highly efficient
method of producing circular RNAs in bacteria. Chimerna has also developed a proprietary affinity tag to
purify circular RNAs from crude lysates. The resulting workflow is rapid, efficient, and scalable, while
generating >90% pure circular RNA. Chimerna scientists have also shown that the ligation junction of these
circular RNA can be mutated so that they are site-specifically amino functionalized by an endogenous
tRNA-guanine transglycosylase. This amino functional group can be conjugated lipids that are widely
available or are simple to activate for conjugation using a routine coupling method. In this way, Chimerna is
able to produce a variety of site-specifically lipid-conjugated circular RNAs that may accelerate endosomal
escape. In this project, we aim to 1) optimize a bacterial strain and expression conditions for high
efficiency amino functionalization. This will involve knocking out genes downstream of the
transglycosylase and knocking in additional copies of upstream genes. 2) improve the endosomal escape
of RNAs by site-specific lipid conjugation. We will test a variety of lipid conjugates to a smaller circular
RNA that is a miRNA sponge, and a larger circular mRNA that is translated by cap-independent translation.
Both RNAs will be encapsulated using standard methods and we will test efficiency of endosomal escape.
Taken together, we will generate a scalable and low-cost method for semi-synthesis of site-specifically
labeled circular RNAs. We will leverage this approach to solve the endosomal escape challenges of RNA
therapeutics delivery.

Public health relevance
PROJECT NARRATIVE RNA vaccines and therapeutics have gained a lot of attention following the success of the mRNA-based COVID-19 vaccines and many new companies are entering the field. Delivery of these RNAs to the cytoplasm is a major challenge due to poor escape from endosomes. This proposal will result in a new method for manufacturing circular mRNAs in bacteria such that the RNA contains a specific site for amine functionalization. Hydrophobic groups improve endosomal escape, so we will generate site-specific lipid- RNA conjugates and test whether this improves delivery to the cytoplasm using well-established protocols.